Determining the cellular and nanoscale localization of Synaptotagmin VII

ABSTRACT
Synaptic dysfunction is linked to numerous devastating neurological and psychiatric disease.
Synaptic transmission is initiated by the calcium dependent release of neurotransmitters. The calcium
sensors responsible for triggering vesicle release are the Synaptotagmins (SYT), a 17 protein family. The
function of one SYT, SYT7, is less well understood but is thought to be of significant importance due to its
broad expression throughout the body and brain, connections to cancer and ALS, and enigmatic function in
the central nervous system. Unlike other Synaptotagmins, SYT7 is thought to be found on the plasma
membrane and its function remains controversial. The role of SYT7 is still under intense debate due to
several outstanding questions regarding its cellular and synaptic localization. Answering these key questions
is the focus of my grant proposal and will provide necessary insights into SYT7’s function.
This proposal aims to answer these questions by determining SYT7’s cellular and nanoscale
localization in cortical neurons using biochemistry and three-color STED super resolution microscopy. Aim
1 will determine whether SYT7 is found on the cell surface of cortical neurons using live-cell surface protein
biotinylation and live-cell surface staining in mouse cortical slices and rat primary cortical neurons. Aim 2
will determine how SYT7 is organized at synapses using three-color STED staining for endogenous synaptic
proteins. Aim 3 will determine whether neuronal activity regulates the cellular and nanoscale localization of
SYT7 using both surface protein biotinylation and live-cell surface staining with three-color STED.
This proposal is designed to provide me with intellectual and technical training throughout the
fellowship award. I will learn key biochemical assays, ex vivo slice preparations, and will hone my skills in
advanced STED super resolution microscopy. With support from this award, the training during this
fellowship will provide me with the skills necessary to become a successful physician scientist.

Public health relevance
PROJECT NARRATIVE Fast and efficient neurotransmission is essential for normal brain function, and a thorough understanding of how synapses are organized is essential to our understanding of neurological diseases. The pre-synaptic calcium sensor Synaptotagmin VII (SYT7) has been recently linked to Bipolar Disorder, ALS and numerous cancers, yet its localization in neurons remains debated. Here, we will answer key outstanding questions surrounding SYT7 by determining its cellular and nanoscale localization at synapses.